A Ram Model of Neuroendocrine Function

Project Summary
Our long term goal is to characterize, expand and improve knowledge of the developmental and
neurobiological determinants of sexual partner preferences/orientation using domestic sheep as the
experimental model. The sheep is an exceptional model because variations in male-typical sexual partner
preference occur spontaneously, with as much as 8% of the ram population exhibiting mating preferences for
the same-sex. Sheep have a long period of gestation making them an ideal experimental model for the study of
possible links between fetal neuroendocrine programming and adult sexual behavior. Similar to humans, sheep
possess a sexually dimorphic preoptic nucleus (SDN) that is larger in males that are attracted to females than in
males that are attracted to other males. The ovine SDN develops prior to birth and is enlarged by testosterone
(T) exposure during a prenatal critical period that occurs after the external genitals have sexually differentiated.
We recently discovered that the hypothalamic-pituitary-gonadal (HPG) axis is active during the critical period
suggesting that variations of T exposure in males could be centrally mediated through control of gonadotropin
releasing hormone (GnRH) secretion. In adults, GnRH neuron activity is regulated by inputs from afferent
neurons that co-express kisspeptin (KP), neurokinin B (NKB) and dynorphin (DYN) and are referred to as KNDY
neurons. KNDY neurons are reciprocally interconnected and critical to the control of pulsatile GnRH secretion
and steroid feedback. We reported that KP, NKB, DYN and their receptors are expressed in the fetal lamb
hypothalamus. However, whether a functional circuit is established among KNDY neurons and GnRH neurons
in the fetal lamb brain is not yet known. The goal of this proposal is to test the hypothesis that KNDY-GnRH
signaling plays a pivotal role in the activation/regulation of the reproductive axis during fetal
development and is responsible for masculinizing sexual partner preferences by controlling T secretion
by the fetal testes. My laboratory and collaborators have extensive expertise with the ram model and with the
methods needed to elucidate the mechanisms involved in programming the functions of the brain that control
neuroendocrine functions and sexual attraction. Our specific aims include: 1) Behavioral studies of rams
prenatally treated with a GnRH antagonist to determine if GnRH control mechanisms that regulate fetal T
secretion play a direct role in establishing adult male-typical sexual preferences; 2) Physiological studies using
chronically catheterized non-anesthetized lamb fetuses to determine if KP, NKB and DYN regulate GnRH
neurons and consequently pituitary LH and testicular T secretion during the critical period; 3) Anatomical studies
to determine when during early development the neuronal components of the KNDY-GnRH neural circuit are
established and how they are regulated. Our sheep model is unique because it allows us to identify mechanisms
underlying sexual partner preference without the confound of having subjects that differ in sex as well as in
sexual orientation. Advancing the sheep model bridges research interests of NICHD, NIMH and NINDS.

Public health relevance
Project Narrative. Fetal development is a time when critical neuroanatomical and physiological components of the reproductive system are established and determine the sexual phenotype and reproductive health of the adult individual. The proposed studies will illuminate essential hormonal, neural and cellular mechanisms that activate the fetal reproductive axis, and will contribute to our understanding of underpinnings of brain sexual differentiation, especially in relation to sexual partner preferences. Advancing the sheep model is an important resource effort to provide a valuable large animal model for research that bridges the priorities of NICHD (basic mechanisms of fetal development); NIMH (define the neural mechanisms of complex behaviors) and NINDS (understand how the normal brain and nervous system develop).